Studying macrophage polarization in search for predictive and prognostic markers of breast cancer

Project Summary
Ductal carcinoma in situ (DCIS) is the most common form of breast cancer, with 50,000 women diagnosed with
DCIS annually in the U.S. Although only 20-30% of DCIS lesions will progress to the invasive disease (IDC),
97% of DCIS patients will undergo surgery with or without radiation. Therefore, markers of DCIS progression to
IDC are urgently needed to prevent overtreatment. However, the events leading to DCIS progression are
unknown, and previous studies have shown that they cannot be explained by genetic and transcriptomic
changes in tumor cells. This suggests that elements of the tumor microenvironment (TME) other than cancer
cell-intrinsic events might play a role in the transition from in situ to invasive breast cancer. Macrophages are
one of the most abundant immune cell type in the TME, that survey the tissue, react to its changes, and
orchestrate the immune response, making them ideal biomarker candidates. In the previous funding cycle, we
demonstrated that several macrophage subtypes endowed with different functions and relations to cancer
exist. We established the first human macrophage subtype-specific markers that, combined with novel
formalin-fixed paraffin-embedded (FFPE) tissue-compatible profiling technologies, enable the study of the
contribution of individual macrophage subtypes to tumor immunity using archival tissue specimens with known
clinical outcome. In addition, we have extensive prior experience with breast carcinoma research and have
access to well-studied cohorts of DCIS and IDC with long clinical follow-up. To this end, we found that a higher
overall abundance of macrophages in DCIS predicts tumor progression to IDC. In addition, in the preliminary
data to this renewal, we reveal a novel and previously overlooked human intraepithelial tissue-resident
macrophage population located between the basal and luminal layers of the breast gland and show that it
acquires distinct transcriptional signatures upon transition from normal breast epithelium to DCIS, supporting
the notion that changes in macrophage compartment might be leveraged as markers of breast cancer
development.
Aim 1 will study how different macrophage subtypes change in the early events that lead to DCIS tumor
formation and progression to IDC, while Aim 2 will seek to identify macrophage-specific markers of tumor
progression from DCIS to IBC. Aim 3 will reveal the cellular interactions and molecular signaling shaping
different macrophage functions by studying macrophage crosstalk with other tissue cell types, focusing on
macrophage interactions with the most abundant TME cells—fibroblasts.
The studies in this proposal will improve our understanding of the biology of breast cancer development and
identify new prognostic markers and predictors of DCIS progression. Therefore, the proposed research is
relevant to the NIH’s mission to develop fundamental knowledge that will help reduce the burdens of human
disability and disease.

Public health relevance
Project Narrative In the previous funding cycle, we developed the first human macrophage subtype-specific markers and showed that distinct macrophage populations are spatially segregated in the tissue, associate with different non-myeloid cells, and display distinct functions. Here, we use the newly established macrophage markers to study how distinct macrophage subtypes react and contribute to breast cancer initiation. The studies of this proposal will lead to a better understanding of breast cancer biology and the identification of new prognostic markers and predictors of in situ breast cancer progression to invasive disease.